Forsyth Training in Oral Health Research

Contact PD/PI: Van Dyke, Thomas
In this competing renewal of the Postdoctoral Training Program at the Forsyth, we are excited to propose the
expansion of our program to include the DMD/PhD program at our long-time affiliate, Harvard School of Dental
Medicine (HSDM). The underlying rationale is to build on the strengths of our current separate training programs
that focus on the development of research-focus dentist scientists and oral health researchers and to broaden
the scope to include both predoctoral and postdoctoral applicants for academic careers in the NIH funding
environment. This application seeks to integrate valuable and synergistic features to enhance the pipeline of
dentist scientists and oral health researchers. We will build on the strength of our NIH-sponsored T90/R90
postdoctoral training program to develop a diverse group of committed, highly trained and competitive
investigators who seek to obtain collaborative, multidisciplinary research training (basic, translational, or clinical)
applicable to oral and craniofacial diseases, conditions and disorders that will take advantage of the most current
scientific and collaborative strategies. Collaborative and multidisciplinary research is emphasized, in part, by
recruiting trainees into collaborative investigations within or between broadly focused researchers at Forsyth and
HSDM. The program is guided by an Internal Advisory Committee (IAC), led by Dr. Thomas Van Dyke (Program
Director), Dr. Yingzi Yang (Co-Director) and Dr. Xuesong He (Assistant Director). Expert biannual program
review is provided by an External Advisory Committee of Drs. Jane Weintraub (University of North Carolina),
Jeffrey Ebersole (University of Nevada, Las Vegas) and Charles Serhan (Harvard Medical School). The program
provides support for six trainees per year; 4 postdoctoral and 2 DMD/PhD. Trainees will take required
courses/workshops including Responsible Conduct of Research, Methods for Enhancing Reproducibility,
Elements of Grant Writing, Grant Review and Support, Maximizing the Mentor-Mentee Relationship, and
Effectively Communicating Research. Additional elective and non-elective opportunities will be tailored to the
individual's needs and programs. Tutorials and seminars in grantsmanship, grant writing skills, and successful
teaching and presentation are each part of trainees’ programs. There are also opportunities for mentoring high
school student summer research which not only provides trainees with valuable mentoring experience, but also
enriches the pipeline for those selecting research-intensive health-related careers in the future. Trainees’
progress is reviewed weekly by the mentor and semiannually by program staff for reappointment and guidance.
An IAC member is assigned to each trainee for guidance and assistance in grant preparation/review. All
postdoctoral trainees are required to prepare and submit a K or R grant application and DMD/PhD’s are
encouraged to submit F31 applications. Provision is made for informal and formal trainee feedback (current and
post-program) and for trainee tracking following completion of the program.
Project Summary/Abstract Page 6
Contact PD/PI: Van Dyke, Thomas

Public health relevance
Project Narrative This T90/R90 postdoctoral and DMD/PhD training program is intended to provide research training and research education experiences to US and non-US citizens, positioning them as investigators who can successfully compete for research funds in areas of oral health research, clearly and effectively communicate their thoughts both orally and on paper, recognize the value of collaborative and multidisciplinary research interactions, lead and inspire others to accomplish mutual research objectives, know how to translate their findings to practice, be ethical in their decision-making processes, harmonious in their relationships with other scientists, and who know how to acquire new skills as their careers advance. Project Narrative Page 7